IAFF HazMat Worker Health & Safety Training

The International Association of Fire Fighters (IAFF) proposes to continue its worker health and
safety training program to train workers and community partners in order to prevent work-
related harm and improve worker-related health and safety. The built environment has become
more complex due to increased population growth, aging infrastructure, and increased use of
complex chemicals in commercial products and manufacturing processes (Williams, 2016).
Whether responding to a residential structure fire or a chemical industrial plant, responders
have the potential to encounter hazardous materials at almost every incident. Yet, in a recent
survey, less than half of the respondents stated they felt “adequately prepared” for HazMat
incidents and 70% stated that HazMat training was their greatest need (Pike, 2018). Responders
also face other emerging issues including occupational cancer risks, behavioral health issues,
and greater need for individual and community resilience. The IAFF is committed to addressing
these issues through training and education of all of those who may respond to, or be impacted
by, HazMat emergencies. In alignment with the NIEHS’s strategic plan, the IAFF seeks
opportunities to collaborate with organizations that share the common goal of protecting
workers and their communities. Through this grant funding, the IAFF will deliver specialty
courses including HazMat Technician, Confined Space Rescue, Frontline Safety, Peer Support
Training, Resiliency Training, Disaster Response Peer Support Training, Safety Planning
Intervention for Suicide Prevention Training and Community HazMat Education.
Through this continued cooperative agreement, the IAFF will:
1. Utilize advanced GIS and collaborative contact databases to identify and coordinate
outreach to target populations, giving consideration to increasing diversity and training
of underserved populations.
2. Integrate new technologies (such as electronic tablets, an IAFF online library of tools and
resources, mobile hotpots, web-based applications, etc.) for course delivery, ensuring
consistent, engaging deployment to all students while also improving access to
technology across all populations.
3. Employ multiple robust quality assurance protocols to provide defined benchmarks,
measure training effectiveness, and implement program improvements as needed. The
IAFF is dedicated to ensuring the training program meets and exceeds the NIEHS
Minimum Training Criteria Document.

Public health relevance
The International Association of Fire Fighters (IAFF) has been a partner with the National Institute of Environmental Health Sciences (NIEHS) Worker Training Program (WTP) since 1992, delivering over 1,630 classes and training more than 33,542 workers likely to respond to hazardous materials incidents, in an effort to prevent work related harm and improve worker health and safety. In addition to delivering highly technical training for HazMat incident response (e.g., Confined Space Rescue and Operations, HazMat Technician), the IAFF remains committed to delivering holistic training to address all aspects of worker safety including emerging topics such as occupational cancer risks, opiate and substance abuse disorders, behavioral health awareness, suicide prevention, and improving individual/community resiliency. The IAFF is committed to addressing these issues, by: continuing and improving the training and education of all potential responders (public, private, volunteer, community partners) who may be impacted by HazMat emergencies; utilizing innovative technologies for class delivery; and conducting ongoing quality control and program evaluation.